Treating neurotoxicity and cognitive deficits due to hyperphosphorylated tau.

PROJECT SUMMARY (Description)
Hyperphosphorylated tau is the major component of neurofibrillary tangles existing in the brains of Alzheimer’s
Disease patients, but whether soluble hyperphosphorylated tau oligomers are already toxic to neurons, and if
so, through what mechanisms, have remained unclear. This is largely due to the lack of experimental system
to tackle these questions directly. This project will test the hypothesis that hyperphosphorylated tau oligomers
promote neurotoxicity before the formation of insoluble tau fibrils, which is amplified by Ab peptides and/or the
ApoE4 allele, but either apomorphine and raloxifene treatment mitigates these deleterious effects. This project
has three specific aims.
Aim 1 will compare the effects of intrahippocampal injection of tau and hyperphosphorylated tau (hyper-ptau) in
wildtype and AD-mutant mice (J20 and ApoE KI). We will also compare the onset of behavioral/histological deficit
and insoluble tau fibrils in these mice after intrahippocampal injection.
Aim 2 will test the effects of hyper-ptau on the viability, mitochondrial functions, and axonal trasnport of cultured
neurons. We will also confirm mitochondrial dysfunctions after brain injection of hyper-ptau in vivo.
Aim 3 will test the protective effects of apomorphine and raloxifene in preventing hyper-ptau-induced toxicity
and cognitive deficits in mice. Both compounds attenuates ptau aggregation in vitro and have a high potential
to be repurposed for clinical treatment of AD.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT According to the CDC database, 6.5 million (10.7%) of Americans aged 65 and older are living with Alzheimer’s disease in 2022, while there are no potent medicines to prevent its onset or progression. In this project, we will test a novel pathogenesis hypothesis and two treatments that target the aggregation of hyperphosphorylated tau. Positive outcomes of this project will shed insights to the mechanisms of Alzheimer’s dementia and may suggest new treatments of this devastating disorder.